Saccade motor control: The role of cerebellum in spatial updating of saccades

Project Summary/Abstract
The accuracy and precision of saccades are important to vision. Our long term goal is to identify the neural
mechanisms that underlie saccade motor control. As with other movements, the cerebellum plays a key role in
fine tuning saccadic eye movements. Specifically, intact oculomotor vermis (OMV) and caudal fastigial
nucleus (cFN) is critical for producing accurate saccades. Much of our understanding of the physiology of
neurons in the cFN and Purkinje (P-) cells in the OMV during saccades has relied on saccades made to single
targets that appear in the visual periphery. In such a visually guided saccade task, the vectors of the
retinotopic target and the saccade motor command are congruent. However, in real life, saccades often must
be coordinated with other saccades or other types of eye movement that intervene between the programming
and execution of a saccade. Such interruptions dissociate the vector of the saccade to be executed from its
retinotopic target vector. The brain must update the vector of the upcoming saccade by combining the
retinotopic target vector with information about the intervening movement. Oculomotor areas of cerebral cortex
account only partially for the spatial updating of saccades, implying significant contribution from subcortical
structures. We hypothesize that the OMV and the cFN to which it projects play critical roles in this process.
These structures receive motor command feedback from brainstem saccade premotor neurons. The feedback
signal could be used to adjust the motor command of the final saccade during spatial updating via cFN
projection to saccade premotor neurons. We will test this hypothesis in a monkey performing a double-step
saccade task (DST). In this task, the monkey makes two sequential saccades in the dark to previously flashed
visual targets. The task requires the brain to combine the motor command of the first saccade with the
retinotopic location of the flashed second target to produce an accurate second saccade. Specifics Aims 1 and
2 examine the activity of neurons in the cFN and OMV P-cells during spatial updating of saccades. We will test
the hypothesis that by combining the retinotopic target signal in the SC with the feedback motor command of
the first saccade of a DST, the cerebellum computes a corrective signal. This corrective signal is represented
in the saccade-related activity of the neurons. Specific Aim 3 perturbs the processing of spatial updating of
saccades before the second saccade is launched. We will briefly increase P-cell activity by using optogenetic
activation triggered by the first saccade, and examine the effects on the second saccades.
Overall Impact: The cerebellum plays an important role in the accuracy, precision, and temporal
sequencing of movements. We will study the cerebellum’s contribution to the coordination of a sequence of
saccades—well understood movements that provide a platform for understanding motor coordination more
generally. The results of our studies will improve our understanding of the neural basis of motor coordination
and will guide the development of behavioral strategies to rehabilitate patients with cerebellar diseases.

Public health relevance
Project Narrative This proposal studies the neuronal mechanisms of saccadic eye movement that keeps the eye movement accurate which is critical to normal vision. We will investigate different neuronal pathways that serve saccadic eye movements in different behavioral contexts. The results of this project are relevance in the diagnostics, treatment and rehabilitation of patients with saccadic eye movement disorders and other movement disorders.